Building next generation sequencing capacity at Wisconsin Veterinary Diagnostic Laboratory for diagnosis of COVID-19 (SARS-CoV-2 infection) in animals

Project Abstract
The goal of this proposal is to build viral whole genome sequencing capacity at the Wisconsin
Veterinary Diagnostic Laboratory (WVDL) for sequencing of SARS‐CoV‐2 from animal samples. We are
requesting funding for consumables, equipment, and personnel time to perform SARS‐CoV‐2 whole
genome sequencing. We will purchase an IndiMag48S nucleic acids extraction platform, which is critical
equipment for high‐quality samples preparation, and a nucleic acid workstation to use for library
preparation. We will also purchase an Oxford Nanopore Flongle long read sequencing platform to
provide cost effective capacity to sequence small sample caseloads without the need to batch samples.
We will validate library preparation and sequencing protocols using published reagents in ARTIC
protocol and a commercial NEBNext sequencing kit (New England BioLabs). A high computing power
machine will be purchased to support the computation demand in bioinformatics analysis of the SARS‐
CoV‐2 sequencing data. We will develop and provide standard operating protocols and analysis
programing to veterinary diagnostic personnel to maintain proficiency in sequencing and data analysis,
and fast and economically efficient in SARS‐CoV‐2 genomic lineages determination. We will use these
tools to train our staff and expand our capacity and capability to support diagnostic activities for the
ongoing global SARS‐CoV‐2 pandemic. Additionally, this proposed work will indirectly improve WVDL's
readiness for immediate impact and response during future animal and public health disease
outbreaks.

Public health relevance
Project Narrative This proposal will build capacity at the Wisconsin Veterinary Diagnostic Laboratory (WVDL) with the development and validation of a SARS‐CoV‐2 WGS methodology and training of staff. Funding is requested for the purchase of reagents and equipment to validating a targeted SARS‐CoV‐2 sequencing workflow using the MinION and Flongle (Oxford Nanopore) platforms. This project will further our capacity and capability to support diagnostic activities for the ongoing global SARS‐CoV‐2 pandemic and prepare for translation to other veterinary important diseases.